Structural and functional studies of CALHM channels

PROJECT SUMMARY
Purinergic signaling plays fundamental roles in activities of the nervous system as diverse as neuroprotection,
synaptic transmission, nociception, inflammation, hearing, and taste. This process is initiated by releasing
adenosine triphosphate (ATP) across the membrane through either classic exocytosis or ATP-permeable
channels into the synaptic cleft, where the ATP binds downstream receptors on an adjacent cell. There are five
families of ATP release channels: connexins, pannexins, volume-regulated anion channels, maxi channels, and
calcium homeostasis modulators (CALHMs). Highly expressed in the brain and taste buds, CALHM channels
play essential roles in taste and neuron transmission, and their dysregulation has been associated with various
neurological disorders including Alzheimer disease, ischemic brain damage, and depression, making CALHM
channels important pharmacological targets.
The CALHM family consists of three members, CALHM1, 2, and 3. They are voltage-dependent, extracellular,
calcium-concentration-regulated, nonselective ion channels that are permeable to the signaling molecules ATP
and calcium. They are predicted to share membrane topology with connexins, pennexins, innexins and VRACs.
Functional studies provide a consensus view that CALHM1 forms a hexameric channel and that it forms only
hemichannels, but not gap junctions. CALHMs activity is modulated by a wide range of factors including
ruthenium red, Gd3+, and 2-APB. Although CALHMs are central to human physiology and are potential
therapeutic targets, there are no structures of this family. We do not understand, in molecular detail, how the
channel is activated or inhibited, or how it is modulated by small molecules binding at specific sites.
We have published strong evidence that CALHM2 is undecameric and exists as both hemichannels and gap
junctions in vitro. We have determined cryo-EM structures of human CALHM2 in the Ca2+-free open state, and
ruthenium red–bound inhibited state. These preliminary results provide not only the first atomic structures of a
CALHM family member, but also the first bona fide structure in an inhibited state, which has never been reported
for channels with similar topology including connexins, pannexins, innexins and VRACs. We observed a binding
site of ruthenium red that was completely unknown before. Building on this preliminary data, we propose to
continue the structural studies of CALHM2 and the other two family members, CALHM1 and CALHM3, combined
with complementary electrophysiology experiments and other functional approaches, to define the molecular
basis for a comprehensive gating mechanism and the molecular determinants and function of gap junction
formation, as well as their pharmacology. These advances will provide a solid foundation for developing new
drugs against neurodegenerative diseases and for a deeper understanding of the function of the ATP release
channel family and the gap junction family.

Public health relevance
PROJECT NARRATIVE Calcium homeostasis modulators (CALHMs) constitute a family of nonselective ion channels that are permeable to the signaling molecules calcium and ATP; they are thus critically involved in calcium and purinergic signaling. The proposed study focuses on uncovering the oligomeric state, multichannel assembly, molecular structure, gating mechanism, and pharmacology of the CALHMs, taking advantage of single- particle cryo-EM, electrophysiology, and other functional approaches. The proposed research is relevant to public health and NIH's mission because this work will provide a deep understanding and broaden our knowledge of the relationships between atomic structures and the complex biological and pathological functions of CALHMs, paving the way for the development of therapeutics to treat neurological diseases including Alzheimer disease, ischemic brain damage, and depression.